Longitudinal behavioral, sociodemographic and contextual predictors of young adult sleep health and well-being

Project summary
Sleep health is a public health priority. Socioeconomic and ethnoracial differences in sleep (“social disparities in
sleep”) across childhood and adolescence may contribute to the emergence and persistence of health
disparities into young adulthood, a transitional period dense with many key life events. Leveraging the Fragile
Family and Child Wellbeing Study (FFCWS) data collection, the proposed research will investigate the
longitudinal behavioral, sociodemographic, and contextual predictors of young adult sleep health, and the extent
to which youth sleep health trajectories and other health behaviors contribute to disparities in young adult
wellbeing. As a sub-study of the age 22 wave of the FFCWS, this renewal proposal will collect sleep and health
behavior data in Aim 1. First, we will add sleep-related questions to the age 22 young adult general survey in the
full FFCWS cohort (n~3600). Then, on a subsample of approximately (n~900) adolescents who participated in
the age 15 actigraphy data collection, we will collect 14 days of actigraphy data for sleep and physical activity,
with a concurrent smartphone-based, twice-daily diary app collecting screen use and self-reported activity data
(e.g., substance use, diet). This study enables the first actigraphy-based analyses of sleep trajectories from
adolescence into young adulthood. In Aim 2, we seek to identify the magnitude of sleep health disparities in
young adulthood, and the extent to which contextual and behavioral factors account for social disparities in
sleep. We hypothesize that ethnoracial minorities and those with early life lower SES will continue to exhibit
poorer sleep health in young adulthood, and that these differences are partially accounted for by family and
contextual factors, sleep and health behaviors, and the autonomy and constraints of young adulthood. In Aim 3,
we will assess how sleep health trajectories across childhood and adolescence are associated with wellbeing in
young adulthood, including physical health, social-emotional health, and socioeconomic wellbeing. In Aim 4, we
will model within-person temporal dynamics between health and health risk behaviors (i.e., physical activity,
pre-bed screen time, substance use, diet) and sleep health using two weeks of actigraphy and daily diary data.
Here we hypothesize that, within a person, engaging in health risk behaviors (e.g., pre-bed screen time,
sedentary activity, substance use) will adversely affect that night’s sleep, and that positive health behaviors (e.g.,
physical activity) will benefit that night’s sleep. We further hypothesize that sleep has within-person effects on
next-day activities (e.g., more sleep duration is associated with more next-day physical activity). The proposed
rigorous actigraphy-based investigation of sleep trajectories from childhood through age 22 advances our
understanding of social disparities in sleep health and wellbeing in young adulthood. Mechanistic insights
regarding the role of modifiable behaviors (e.g., bedtime routines, screen use behaviors, physical activity,
substance use, diet) and contextual factors can influence the development, implementation, and evaluation of
policies and interventions to reduce sleep and health disparities and improve wellbeing of young adults.

Public health relevance
Project Narrative Sleep health is a public health priority. The proposed research investigates the longitudinal predictors of young adult sleep health and the extent to which sleep health trajectories and specific health behaviors (i.e., physical activity, substance use, and pre- bed screen use) contribute to sleep and health disparities in young adulthood. This study will inform public health policy, health recommendations, and interventions seeking to improve sleep, health, and wellbeing in young adulthood.